Mechanisms of Protein Aging in Normal and Cataractous Lenses

ABSTRACT
Cataract is the leading cause of blindness worldwide. Surgical removal of cataractous lenses
places an enormous financial burden on our economy and is not without side effects. Moreover,
the prevalence of cataract in the U.S. is expected to more than double by the year 2050.
Although new therapies are being developed to prevent or reverse early cataract, our
understanding of the underlying mechanisms of cataractogenesis remains unclear. The long-
term goals of our research are to identify modifications to lens proteins during aging and
cataractogenesis in order to define protein aging mechanisms and to develop ways to prevent,
delay, or reverse opacification. Recently, we have identified multiple age-dependent, non-
enzymatic biochemical processes that result in both age-related lens protein modification and
cataract-related lens protein crosslinking. The lens proteins and amino acids involved have
been identified; however, mechanistic details remain unresolved. In addition, we have observed
a dramatic re-distribution of soluble lens proteins to the membrane fraction in aged lens tissue.
Again, the operative mechanism(s) of this protein shift remains unknown. Our hypothesis is that
specific lens protein-protein crosslinks, peptide/lipid alterations, and crystallin binding to lens
membranes are cataractogenic. To test this hypothesis we will employ state-of-the-art imaging
mass spectrometry and proteomics/lipidomics methodology to further define age-related and
cataract-specific modifications and define conditions upon which the chemistry occurs to
determine chemical mechanism. Specifically we propose to: 1) define the protein sites and
chemistry of protein crosslinks in cataractous human lenses and, 2) define cataract-specific
peptide and lipid changes in human lenses, and 3) elucidate the molecular events that lead to
increased lens protein membrane binding with age and cataract formation. The proposed
experiments are expected to provide new mechanistic details on protein aging that will not only
inform the development of new cataract treatments, but also guide therapeutic development for
other aging and protein aggregation diseases.

Public health relevance
Project Narrative The relevance of the proposed studies is that with an improved understanding of lens protein aging and cataract formation, therapies can be developed to prevent or delay the onset of cataract in our increasingly aging population. In addition, the long-term outcomes are expected to reduce the enormous financial costs of cataract treatment and also impact treatment of other aging diseases.